Genome Integrative Pathway Modeling of Diabetic Atherosclerosis

DESCRIPTION (provided by applicant): Diabetes without previous coronary heart disease (CHD) carries a lifetime risk of vascular death as high as that for people with CHD. The goal of this project is to explore and discover novel and more complete regulation mechanisms of atherogenic pathways in diabetes by developing advanced statistical analysis and novel pathway modeling capabilities and techniques based on microarray data collected from animal disease progression models and combined with various functional and genomic database resources. Microarray profiling experiments that follow different diabetic progression conditions of well-established animal models will be cost-effectively executed to obtain genome-wide gene expression information for their atherogenic pathway conditions (measured from visceral fat tissue-derived adipocytes and macrophages). We will carefully examine the atherogenic pathway mechanisms, especially those associated with 12/15-LO and PPARg, which have been targeted by our primary pathway investigation due to their critical physiological roles in atherosclerosis. In particular, the latter has been identified as one of main pharmacological targets for treating cardiovascular complications among type II diabetes patients. Our specific aims are to: 1) discover atherogenic pathway genes, especially relevant to 12/15-LO and PPARg at different stages of diabetic atherosclerosis progression by developing and applying advanced statistical analysis approaches to microarray data on different diabetic animal-model conditions with a small number of replicates, 2) develop a formal language (FL) framework and its genomic information database for various expression and functional information of 12/15-LO, PPARg and other atherogenic genes that will be identified from the time-course microarray data of diabetic animal models and for the genes known for their functions and mechanisms in atherosclerosis, and 3) discover novel atherogenic pathway mechanisms in diabetes, especially those associated with 12/15-LO and PPARg by developing and applying genome integrative pathway modeling (GIPaM) technology. Novel findings from these investigations will directly benefit the diagnosis and treatment of atherosclerotic cardiovascular disease. Our GIPaM technology will also greatly enhance pathway discovery/modeling capability in other fields of the biomedical science.